Developing a Toolkit for Transgender and Gender Diverse-Affirming Health Communication: A Community-Based Participatory Research Partnership Approach

Abstract
Message tailoring in public health campaigns is especially important in health disparate minority populations,
such as transgender and gender diverse (TGD) people, that often have barriers to care that include distrust of
the health system, societal stigmatization, and financial barriers. TGD health disparities include, for example,
elevated rates of diabetes, cardiovascular disease, anxiety, depression, and substance abuse compared to
rates for cisgender populations. Furthermore, the TGD population is subjected to societal exclusion and
negative public perception that contributes to exacerbating these problems. However, little to no attention is
paid to TGD populations when designing health promotion campaigns for conditions for which this population
has elevated risk, even though the effectiveness of such campaigns is well-documented for the general
population. Health promotion messaging that can engage TGD people in needed care and prevention activities
is an essential tool in addressing their health disparities. However, launching specific health promotion
campaigns for a host of health conditions in health disparate populations, such as TGD communities, is not
feasible due to the volume of specific conditions needing to be addressed individually. Furthermore, national
health promotion campaigns with TGD populations in mind can still fail to reach TGD communities in the
Central Great Plains because they do not match the lived reality of this region with the compounding issues of
high stigmatization, and less access to care than in coastal regions. To overcome these challenges, this
project will use a community-based participatory research network to build a TGD-affirming toolkit for health
communicators to use to tailor messages to this community with the following specific aims: 1) Identify and
explore potential barriers to care generated through non-TGD tailored health communication aimed at Type 2
diabetes, anxiety and depression, colorectal cancer, substance abuse, and cervical cancer. Through a series
of interviews with TGD individuals in the Central Great Plains and national TGD content creators, the impact of
both non-TGD specific and TGD-specific health messages will be explored. Qualitative and critical cultural
analyses coupled with iterative feedback from community and national boards will generate a preliminary
toolkit of TGD-affirming principles for health communication. 2) This toolkit will then be tested through an
innovative dialogic workshop in which health communication professionals apply the toolkit to a health
promotion campaign and share it with TGD community members, and communication professionals who
identify as TGD, ending with any needed revisions of the toolkit. The multidisciplinary Trans Collaborations
research team has a successful history of federal funding and producing innovative outcomes that have
significant scientific and community impact. The well-established Local Community and National Advisory
Boards inform all projects. Development of a community-informed toolkit for TGD-affirming health messaging is
another step on our long term goal of addressing TGD health disparities in underserved areas.

Public health relevance
Project Narrative Through a community-based, iterative development process, we will partner with the Central Great Plains Transgender and Gender Diverse (TGD) community to develop a toolkit to guide the development TGD- affirming health communication and promotion activities. The developed toolkit will be piloted by 10 health communication practitioners to develop TGD-affirming materials for specific health conditions. These materials will then be reviewed by the community in a dialogic focus group with the aim to refine the toolkit for future efficacy and acceptability testing.